Cancer Biology Training Program

Project Summary/Abstract
The Cancer Biology Training Program (CBTP) at the University of Michigan, currently in its
twenty-fifth year, is an interdisciplinary program whose central goal is to train exceptional junior
investigators to address fundamental biological problems related to human cancer. The CBTP
appoints three predoctoral and three postdoctoral scholars annually for up to two years each,
with independent research opportunities focusing on a wide choice of topics in the field of
cancer biology. In addition, the CBTP provides these trainees with didactic coursework and
programmatic activities, including retreats, visiting speaker series, and research-in-progress
seminars, that expose them to the depth and breadth of cancer research across diverse
disciplines. The CBTP draws its strength from: the participation of 36 faculty members from 20
basic science and clinical departments and programs within the University of Michigan; its
association with the University of Michigan Comprehensive Cancer Center (UMCCC); and its
involvement with the Program in Biomedical Sciences and Medical Scientist Training Program,
through which graduate students are recruited. Senior CBTP faculty are all leaders in their
respective fields and have outstanding track records of research productivity and of mentoring
young scientists. Junior CBTP faculty have demonstrated potential to develop into future
leaders and display a strong commitment to mentorship and training. Administrative oversight of
the CBTP will be performed by the PI/PDs, Drs. Castro and Lawlor, in consultation with two new
associate directors (Drs. Canman and Lombard) and the CBTP steering committee. Ongoing
evaluation of the program and its leadership will be performed by the UMCCC leadership, CBTP
faculty members, the external advisory board, and by the trainees themselves, especially in the
first three years following graduation from the program. Postdoctoral fellow appointees will have
completed a Ph.D. degree in one of the physical or biological sciences no more than two years
prior to appointment to the CBTP. M.D. and M.D./Ph.D. trainees with a clear commitment to
pursuing independent careers in academic cancer biology research will also be eligible for
appointment. Predoctoral students will comprise a subset of students in their second or third
year of graduate school who have been accepted into the Doctoral Program in Cancer Biology.
All trainees will have demonstrated a significant interest in pursuing a career in some aspect of
cancer-related research. Predoctoral trainees will be expected to graduate to outstanding
postdoctoral positions, while postdoctoral trainees should assume independent research
positions in academia or industry.

Public health relevance
Narrative The Cancer Biology Training Program (CBTP) is an interdisciplinary program whose central goal is to train exceptional junior investigators to address fundamental biological problems related to human cancer. The CBTP trains both predoctoral and postdoctoral scholars with research opportunities focusing on a wide choice of topics in the field of cancer biology. Through selective appointments, didactic coursework and transdisciplinary programmatic activities, the CBTP is creating a diverse pipeline of young investigators who will have a lasting impact on cancer research.